Large-Scale Characterization of ToxCast Compounds and Their Metabolites by High-Throughput Ion Mobility-Mass Spectrometry: Applications in Human Exposome Studies

PROJECT SUMMARY
The exposome refers to the complete array of non-genetic factors that an individual experiences during their
lifetime. Accurately measuring the chemical exposome, which may provide novel insights into environmental
determinants of chronic disease, presents significant analytical challenges. Complex interactions between
co-exposures can occur but are difficult to quantitatively predict. These mixture effects are likely due to the
heterogeneous nature of common environmental chemicals, which represent thousands of classes and span
vast concentration ranges in human blood. Additionally, inter-individual variation in xenobiotic metabolism
can lead to different toxicological outcomes within an exposed population. High-resolution mass
spectrometry (HRMS) has emerged as a powerful technique for broadly profiling xenobiotics and their
transformation products in complex matrices. Despite recent advances in HRMS-based exposome analysis,
however, there is a paucity of MS reference data for common environmental chemicals and their metabolites.
There also remains a crucial need to harmonize measurements of exposome molecules across different
laboratories and instrumental platforms. To address these challenges, we propose the development of large-
scale, multidimensional reference databases dedicated to common environmental chemicals in the ToxCast
library. These databases, which are essential for MS-based compound identification workflows, leverage ion
mobility-mass spectrometry (IM-MS) to enhance selectivity and provide additional structural information.
Gas-phase analyte ions in IM-MS are rapidly separated by size and shape using a dynamic electric field
(traveling wave IM; TWIM) with a neutral buffer gas (e.g., N2). Ions with smaller rotationally averaged surface
area, or collision cross section (CCS), exhibit greater mobility within the drift tube than less structurally
compact gas-phase ions. IM-MS consequently enables three-dimensional separation when coupled to
polarity-based LC separation and mass-based MS. The high inter-day and inter-laboratory reproducibility of
TWIMCCSN2 measurements across diverse analyte classes, complemented by its compatibility with high-
throughput analytical workflows, makes IM-MS ideal for confidently identifying exposome molecules in
complex mixtures. Therefore, Specific Aim 1 will utilize LC-IM-MS/MS to create a multidimensional reference
database that incorporates accurate mass-to-charge (m/z), CCS, retention time, and MS/MS fragmentation
spectra for the ~4500 ToxCast compounds. To expand the scope of human exposome research to xenobiotic
transformation products, Specific Aim 2 will focus on elucidating the major phase I/II metabolic pathways of
the ToxCast compounds by human liver. The proposed research will generate crucial reference data for
confidently identifying exposome molecules and their metabolites in complex matrices.

Public health relevance
PROJECT NARRATIVE Since the completion of the human genome project, it has become evident that non-genetic environmental factors experienced over a lifetime (i.e., the exposome) explain a significant portion of disease risk. The paucity of reference data for xenobiotics and their transformation products is a major bottleneck in chemical exposome analysis. This study aims to develop extensive mass spectrometry-based reference databases for common environmental chemicals and their phase I/II metabolites, thereby facilitating the confident identification of exposome molecules in complex matrices.